THYROID HORMONE FOR CHILDREN WITH ATTENTION DEFICIT/HYPERACTIVITY

Resistance to thyroid hormone (RTH), an inherited defect of the thyroid hormone receptor resulting in reduced responsiveness to thyroid hormone, is associated with attention deficit/hyperactivity disorder (ADHD). We have previously observed diminished hyperactivity when these children are treated with thyroid hormone. The aim of this project is to systematically determine the possible benefit of thyroid hormone treatment in children with ADHD with and without RTH.